DISSEMINATION &TRAINING: EDUCATION &GRADUATE &UNDERGRADUATE TEACHING

This segment of the program provides training through consultation with investigators, one-on-one training of investigators who come to the facility, and undergraduate, graduate, and post-graduate research training.